Mapping impact and developing mitigation strategies for climate change-mental health nexus in the context of vulnerable adolescent populations in Kenya

Abstract
Pregnant adolescents in Sub-Saharan-African (SSA) are burdened by significant unmet
health needs including lack of access to mental health services due to rapidly changing
climate and environmental factors. This proposed supplemental study titled “Mapping
impact and developing mitigation strategies for climate change-mental health nexus
in the context of vulnerable adolescent populations in Kenya” will be leveraged on the
ongoing INSPIRE- K43 study to investigate the influence of climate change and related
environmental risks or stressors on adolescents’ mental health and their offspring’s early
development. The proposed study will be conducted in four primary care health
facilities in two geographically distinct regions: Vishakani and Mwanamwinga sites in
Kaloleni, Kilifi County (rural area) and Kariobangi and Kangemi informal settlements in
Nairobi County (urban area). A random representative 200 pregnant adolescents and young
mothers who meet the recruitment criteria (i.e., ages 13-24 years, from these primary care
clinics will be recruited. A set of assessments covering urban climate change indicators,
exposure to environmental stressors (including adverse events), adolescent mothers’ mental
health, medical history quality of life, and their offspring’s development, birth history and
anthropometric, will be assessed for Aim 1. We will also carry out four stakeholder
workshops and focus group discussion (FGDs) (n=40; 6-10 participants) that will share
scientific knowledge, promote awareness, discuss research methods and results, and
explore mitigation and preparedness strategies for Aim 2. Multivariate linear and logistic
regression will be used to analyze quantitative data while thematic network analysis will be
used to analyze qualitative data. This grant would contribute to developing a clearer
intervention that speaks to social and environmental determinants of mental health in Kenya.

Public health relevance
Project Narrative Pregnant adolescents in Sub-Saharan-African (SSA) are burdened by significant unmet health needs including lack of access to mental health services due to rapidly changing climate and environmental factors. This supplement seeks to build on the ongoing INSPIRE- K43 work by generating formative data on two distinct ecosystems- an urban informal settlement context and a rural Coastal community to understand environmental and social determinants of perinatal mental health.